Structure and Function of Protein C

This Administrative Supplement supports studies of the biologic activity of activated protein C (APC), along the lines of this R01 HL052246 project which is focused on the structure-activity relationships of protein C and APC. The Supplement will enable provision of well characterized preparations of wild type, plasma-derived APC for studies of the radioprotective activity of wild type APC in large animals, namely Gottingen minipigs.

Public health relevance
Activated protein C (APC) is a blood protease with many remarkable properties, including the ability to reduce death caused by exposure of mice to radiation. This implies that APC or a variant thereof may be useful for protection of humans against the lethal damage caused by exposure to large doses of radiation, as in a nuclear disaster. This Administrative Supplement will enable provision of well characterized preparations of wild type, plasma-derived APC for studies of its radioprotective activity in large animals, namely Gottingen minipigs.